EFFICACY OF IBUPROFEN VERSUS ACETAMINOPHEN IN PYREXIC CHILDREN

This study will investigate the efficacy of ibuprofen and acetaminophen in children who present at the Children's Hospital emergency room. This study will test the following hypotheses: 1) ibuprofen lowers temperature more or longer than acetaminophen mg for mg in children 6 months to 11 years. 2) ibuprofen is more potent than acetaminophen in reducing fever in children 6 months to 11 years. 3) ibuprofen is not associated with significant toxicity.